What makes a responder, a responder? Biomarkers to help identify responders and resistors to high-intensity interval training for lower extremity chronic stroke

Most chronic subcortical stroke survivors have difficulty walking, but few predictors can help identify if a patient
will respond to an exercise regimen and improve their function. To enhance precision rehabilitation for chronic
subcortical stroke patients, personalized aerobic exercise interventions are crucial. This requires the
development of innovative technologies that can identify the essential neurobiological factors to predict
intervention response and enable clinicians to determine individualized rehabilitation targets. Lactate is one
exciting new target that acts as a molecular messenger between the periphery and the brain. In order for lactate
to have an impact on other organs, including the brain, it is essential that there is a substantial increase in its
level in the bloodstream from baseline. When the blood lactate threshold is surpassed during exercise, lactate
acts on the brain metabolically via the TCA cycle. Embedded within the TCA cycle is the means to increase or
decrease neurotransmitter concentrations such as GABA and glutamate. Gamma-aminobutyric acid (GABA),
the brain's major inhibitory neurotransmitter, is a new treatment target that promotes neural plasticity during
stroke rehabilitation. Drawing from the framework of personalized rehabilitation approaches and our preliminary
data, we propose to build a predictive model that can identify if a chronic subcortical stroke patient will respond
to exercise training. This model aims to predict improvements in walking speed by incorporating blood lactate as
an early predictor of exercise response and GABA and cerebral blood flow (CBF) as predictors of the brain’s
potential to respond, in addition to other influencing factors such as comorbidities, demographics, and fitness
levels. The overarching hypothesis is that robust neurophysiological factors driven by lactate can differentiate
responders from resistors and that these factors can be applied clinically as biomarkers to predict functional
outcomes after a 12-week HIIT intervention. We will assess improvements in walking speed in 48 Veterans with
lower limb disability due to chronic subcortical stroke in response to a 36-session (12-week) HIIT intervention.
After the intervention, each adherent participant who improves their walking speed to greater than 0.6 m/s will
be categorized as a responder while each adherent participant who does not improve their walking speed will
be categorized as a resistor. At baseline and after 12 weeks of HIIT we will evaluate walking speed, balance, leg
strength, and endurance to identify resistors and responders to HIIT and collect a) GABA from the primary
sensory-motor leg area using single-voxel magnetic resonance spectroscopy, b) CBF from the whole brain using
pseudo-Continuous Arterial Spin Labeling MRI and c) VO2 max to evaluate change in CRF. During the
intervention, we will collect blood lactate via finger prick during sessions 1, 4, 7, 10, and 28 to assess its potential
as an early predictor of exercise response. In aim 1 we determine if surpassing the lactate threshold during the
first 4 weeks of HIIT predicts the change in walking speed to ≥0.6 m/s, from pre- to post-HIIT. If lactate proves
to be a robust early marker of functional response to exercise, we will have an easy-to-deploy predictor of who
will best benefit from HIIT. In aim 2 we will determine if (a) baseline GABA and/or CBF predict improvements in
walking speed from baseline to after HIIT and (b) if a change in GABA and/or CBF relate to a change in walking
speed. We aim to establish neurophysiological correlates of improving function with HIIT to better understand
the mechanisms. Finally, in aim 3 we will a predictive machine learning algorithm of who will improve their walking
speed with HIIT using factors of blood lactate, baseline GABA and CBF, baseline leg weakness and VO2-max,
pre-stroke fitness, age, sex, and comorbidities. The overarching objective is to develop a model to predict which
Veteran with chronic stroke will respond to a 12-week exercise program.

Public health relevance
Stroke survivors with lower limb disability can improve their walking speed with high-intensity interval training (HIIT) rehabilitation therapy. However, some individuals may not respond to HIIT even when fully adherent to the program. To address this, we propose to build a predictive model that identifies if a Veteran with chronic subcortical stroke will improve their walking speed with HIIT by incorporating blood lactate as an early predictor of exercise response, and inhibitory neurotransmitter gamma-aminobutyric acid (GABA) and regional cerebral blood flow (CBF) as predictors of the brain’s potential to respond, while also taking into consideration other factors such as comorbidities, demographics, and fitness levels.